Achieving American Indian Youth Energy and Mental Health Balance

PROJECT SUMMARY
Type 2 diabetes (T2D) disproportionately affects American Indian communities. American Indian adults are
nearly three times more likely to be diagnosed with diabetes, and 2.3 times more likely to die from diabetes
compared to non-Hispanic Whites 1. The prevalence of diabetes among American Indians is 18% compared to
the national rate of 9% for all-races 2. To address T2D disparities among American Indians, there is an urgent
need for culturally and contextually adapted diabetes self-management programs. To understand 1) the types
of support systems that may be helpful, and available, for individuals living with T2D in Arizona Tohono
O’odham communities and 2) how they may be integrated into diabetes self-management and support
(DSMES), we will partner with a community advisory board to culturally adapt a DSMES intervention. This
intervention will link T2D programming in tribal health systems to existing community programs to enhance
capacity and available resources in a rural Arizona tribal community. Contemporary evidence supports the
interrelationship of T2D management behaviors and numerous social-societal contexts 3-10 recognizing that
externally motivated, individual-based behavior changes for DM management are not sufficient in and of itself.
The integration of social support into diabetes self-management education has demonstrated improvement in
disease self-efficacy and glycemic control, while decreasing T2D-associated health care costs 7. Interventions
addressing the complexity of inter-related systems and T2D management remain largely under investigated,
particularly for American Indian communities 3-6. The first step in address diabetes health disparities for
American Indian populations, and the goal of this research, is to create culturally appropriate behavioral
interventions that are meaningful for American Indians with T2D and their families. The overarching hypothesis
for this application is that a Tribally tailored DSMES intervention will reduce risks for diabetes-related
complications. This research supplement builds upon Dr. Godfrey’s educational and clinical training to launch a
career as a health disparities scholar through hands-on research, transdisciplinary mentorship, scientific
writing, and networking activities. This supplement will directly inform a R01 application to pilot test the
culturally adapted DSMES intervention as compared to current diabetes education and management
processes within the Tohono O’odham Nation and examine feasibility of the multi-level, multi-sector
intervention. Parallel to the parent grant, social support operates as a key component of the proposed
supplement by examining multiple domains of influence to develop an intervention addressing the complexity
of inter-related systems and T2D management. The impact of this work may extend to other American Indian
populations and will contribute new and important information for reducing considerable health burden
associated with T2D for American Indian populations.

Public health relevance
PROJECT NARRATIVE This supplement will support Dr. Godfrey’s career development as a health disparities scholar through hands- on research, transdisciplinary mentorship, scientific writing, and networking activities. She will gain specialized knowledge in the cultural adaptation of social support interventions for T2D, strengthen partnerships with the Tohono O’odham Nation for successful cultural adaptation of the intervention, and ultimately respond to the gaps in the science that perpetuate American Indian diabetes health inequities. Dr. Godfrey’s expert interdisciplinary sponsor team will guide her research training, facilitate integration of her PhD course work to extend knowledge development, and facilitate scaffolding for her independent program of research to inform future work with the Tohono O’odham Nation and expand findings to broader American Indian populations.